Metallothionein-Zinc Axis and Macrophage Memory to Fungi

Project Summary
Fungal infection with Histoplasma species (Hc) is highly prevalent in the Ohio and Mississippi river valley regions
of the US and is a frequent cause of fungal respiratory illness. Macrophages are the frontline effector cells that
engulf Hc but only kill yeast cells upon activation. Emerging evidence indicates that macrophages and other
innate cells develop a “memory” phenotype by remembering a prior microbial encounter. This process has been
referred to as trained immunity. Trained macrophages manifest heightened antimicrobial defenses independent
of T and B cells. Thus, training represents an alternative for improving the outcome of infection in patients with
AIDS or other immunocompromising conditions. Metabolic changes, in particular, elevated glycolysis and de-
creased oxidative phosphorylation are key to the development of trained macrophages. The precise mechanisms
underlying training have not been fully uncovered, and the effect of trained macrophages on Hc resistance is
unknown. We have generated exciting data that training human and mouse macrophages enables them to elim-
inate infection with yeast cells independent of exogenous cytokine activation. Using molecular, immunologic,
and metallomic approaches, we discovered that the labile zinc content of macrophages is diminished during
training concomitant with an elevated expression of the zinc binding proteins metallothioneins (MTs)1&2. Trained
macrophages inhibit Hc growth in a zinc-dependent manner. How the MT-zinc axis influences the development
and execution of memory in macrophages is not understood. In this proposal, we will investigate the hypothesis
that zinc homeostasis is a central element in sculpting macrophage memory. Aim 1 will explore the role of gran-
ulocyte macrophage-colony stimulating factor and low zinc in the development of memory. We chose to study
this cytokine since many of its effects on zinc mirror that of training. Aim 2 will determine how MTs1&2 orchestrate
macrophage training. Aim 3 will decipher how the MT-zinc axis regulates glycolytic reprogramming and investi-
gate how metabolic changes shape the anti-Hc response of trained macrophages. Collectively, these studies
will provide new knowledge regarding zinc regulation of trained immunity.

Public health relevance
Project Narrative Macrophages remember prior microbial encounter to efficiently fight future infection. Zinc homeostasis is important for macrophage immunity to the fungus, Histoplasma capsulatum. We will explore how zinc metabolism shapes macrophage memory and how these macrophages resist this fungal pathogen.